TASK ORDER 04: BIOCOMPATIBILITY TESTING FOR RHAEOS. PERIOD OF PERFORMANCE: 7/14/2025 - 1/13/2026

The Blueprint MedTech program is an NIH incubator that aims to support the innovators by accelerating the development of cutting-edge medical devices for diagnosing and treating disorders of the nervous system. The mission of the program is to catalyze the translation of novel technologies from early-stage development to readiness for first-in-human clinical studies. By providing non-dilutive funding and access to essential resources, including planning support, design and testing services, and expert consultations on regulatory and commercialization issues, the program seeks to facilitate the translation of novel technologies to readiness for first-in-human clinical studies. Its goal is to enhance patient access to safe and effective medical devices while attracting further investment from industry and government.